Investigating the Molecular Mechanisms of Beta-Cell Expansion Factor A-induced Beta-Cell Proliferation

PROJECT SUMMARY/ABSTRACT
Beta-Cell Expansion Factor A (BefA) is a secreted bacterial protein that induces the proliferation of β-cells and
promotes proper endocrine function during early development in both zebrafish and mice. The molecular
mechanisms by which BefA induces β-cell proliferation and metabolic maturation are not known. BefA contains
a structurally conserved SYLF domain that mediates interactions with phospholipids and disrupts membrane
integrity. The broad and long-term objective of this project is to learn the molecular mechanisms by which
BefA impacts pancreatic β-cells. This work has wide-reaching possibilities for the development of therapeutic
interventions for both type I and type II diabetes through a better understanding of β-cell proliferation and
metabolic maturation to aid in the production of human induced pluripotent stem cell-derived β-cells. The focus
of this proposal is to investigate how BefA’s demonstrated membrane perturbing activity promotes β-cell
proliferation and metabolic maturation. In Specific Aim 1, I will utilize single-cell resolution live imaging,
genetic manipulation of zebrafish, and human induced pluripotent stem cells to investigate whether BefA-
induced intracellular calcium signaling promotes β-cell proliferation. In Specific Aim 2, I will utilize imaging of
β-cell mitochondria membrane potential and morphology and human induced pluripotent stem cell derived β-
cells to test whether BefA’s impacts on mitochondria promote β–cells' metabolic maturation. If successful, the
outcome of this proposal will be a new understanding of how membrane perturbation in vivo can promote
proliferation, insulin secretion, and metabolic maturation of the essential insulin-producing β-cells. I aim to
translate my mechanistic findings to advance the in vitro production of functional β-cells for cell therapies of
type I and type II diabetes. Furthermore, the molecular insights I will discover, research protocols I will develop,
and skills I will acquire through these studies will promote my development as an independent scientist, β-cell
biologist, and prepare me for my future career in understanding the molecular mechanisms of microbiome
impacts on host health.

Public health relevance
PROJECT NARRATIVE Understanding the factors that promote the proliferation, full maturation, and function of pancreatic β-cells holds promise for unlocking potential therapeutics and cures for both type I and type II diabetes. Beta-Cell Expansion Factor A (BefA) is a microbiome-secreted protein that induces β-cells to proliferate and secrete insulin. This project will explore how BefA exerts these effects on β-cells through interactions with β-cell plasma and mitochondrial membranes towards the goal of advancing the in vitro production of functional β- cells for cell therapies.